Adapting a Parenting Intervention to Promote Healthy Screen Time Habits in Young Children with Externalizing Behavior Problems

Project Summary/Abstract
The goal of this developmental/exploratory R21 application is to develop and pilot test an adapted screen time
intervention for parents of young children with externalizing behavior problems. As young children's access
and exposure to different types of screen media devices has increased, so has public health concern around
the links between unhealthy early screen media use (including excessive use and exposure to inappropriate
content) and poor child outcomes. Research shows that exposure to screen media and externalizing behavior
problems in young children are linked. Externalizing behavior problems also present a significant barrier to
parents attempting to adhere to screen media use recommendations. Despite these public health concerns,
screen media use interventions have not yet specifically targeted children with externalizing behavior
problems. To address this need, we propose to explore a novel approach to intervening around screen time, by
adapting a behavioral parenting intervention designed for parents of children with externalizing behavior
problems to integrate content around screen time. Leveraging an existing evidence-based parenting
intervention will allow for the intervention to target parenting generally, as well as screen time specific
parenting, without requiring additional resources. This R21 application will focus on adapting a group-based
parenting intervention, the School Readiness Parenting Program (SRPP). The SRPP is an 8-week parenting
intervention based on a group Parent-Child Interaction Therapy model. In total, 55 parents of preschool-aged
children with externalizing behavior problems will be recruited. Following a development phase, we will conduct
a small open trial (n = 15) to assess the feasibility of the screen time adapted intervention and families'
satisfaction and response to treatment. At this phase, we will also pilot a multimodal method of tracking child
screen use using objective data from mobile devices and parent-completed media use logs. Upon making
modifications based on results of the open trial and feedback from an external advisory panel of experts and
community stakeholders, a pilot randomized controlled trial (n = 40) will follow. Parents will be randomly
assigned to receive either the screen time adapted SRPP (n = 20) or the original SRPP (n = 20) program.
Assessment measures will be completed at prettest, posttest, and at a 1 month follow up. We will examine
feasibility and acceptability of the screen time adapted intervention in the randomized controlled trial. We will
also examine children's screen use patterns, including overall screen time, proportion of screen time that is
educational, and frequency of parent-child co-use of screen media. In an exploratory fashion, we will examine
the effect of the intervention on child externalizing behavior problems. The results of the proposed research will
lay the foundation and provide critical pilot data for an R01 application to examine the efficacy of this adapted
intervention across different parenting programs.

Public health relevance
Project Narrative Unhealthy screen media use by young children is of major public health concern due to its links with poor developmental outcomes. Externalizing behavior problems have been identified as a risk factor for excessive screen use in young children and may complicate parents' efforts to adhere to screen media use guidelines, but screen media use interventions have not targeted this at-risk population. Therefore, the proposed research will include the development and pilot testing of an adapted parenting intervention to improve screen media use in young children with externalizing behavior problems.